Oklahoma Rheumatic Disease Research Cores Center

Oklahoma Rheumatic Disease Research Cores Center: Overall
The mission of the Oklahoma Rheumatic Disease Research Cores Center (ORDRCC) is to support and
optimize interactions between basic, clinical, and analytical scientists focused on the pathogenesis, prediction,
prevention, and precision therapeutic selection for rheumatic diseases. Towards this aim, the ORDRCC
integrates 26 established center investigators, 22 junior center investigators (12 within and 10 outside
Oklahoma), and 12 potential scholars to develop early-stage investigators with outstanding promise in
rheumatic disease research. The ORDRCC infrastructure, collections, Cores and Enrichment Program have
helped successfully launch the independent careers of 33 former New Investigators. In addition, our CAP-
certified Biorepository within the Clinical Characterization and Biorepository Core (CCBC) provides access to
well-phenotyped cross-sectional and longitudinal rheumatic disease sample collections. The ORDRCC-
supported collections and biorepository infrastructure are critical resources for many established rheumatic
disease investigators from within the ORDRCC and through inter-institutional rheumatic disease collaborations
and clinical trials. In the past 4 years, the CCBC personnel have assisted with 151 IRB study protocols,
recruitment of 1,282 participants, performed 2,648 cohort study visits and collected/processed 66,068 new
sample aliquots, as well as fulfilled 571 samples or data requests. The CCBC will continue to expand these
collections while providing clinical research units for study recruitment and regulatory assistance. Furthermore,
the CCBC will develop an Innovation Hub to pilot novel clinical research approaches and a clinical trialist
development program. The Human Phenotyping Core (HPC) provides experienced technical personal,
standard operating procedures, training, and analytical expertise to empower ORDRCC investigators to use
cutting-edge technologies, including high-dimensional cytometry, single-cell multi-omics, transcriptomics,
spatial multi-omics, and high-throughput testing of soluble mediators. Together, the CCBC and HPC transform
rheumatic disease investigation and clinical trials by integrating clinical and molecular information to identify
molecularly homogeneous subsets of subjects for use in innovative study design. The Administrative Core
serves as the central management and communication hub for the ORDRCC and co-ordinates a multi-
disciplinary Enrichment Program, including a new rheumatic disease pipeline development program for
underrepresented groups, a mentoring program, a new Science Writing Success Center to assist investigators
with developing robust manuscripts and competitive grant applications, and Expanding Rheumatic Disease
Research Colloquiums to increase outreach and forge interactions between ORDRCC scientists and other
NIAMS Centers. Together, the ORDRCC facilitates and expands collaborative rheumatic disease research by
providing career development, cutting-edge technologies, well-phenotyped clinical data, and fostering
collaborations to improve patients’ lives.

Public health relevance
Overall Project Narrative Rheumatic diseases cause significant morbidity and early mortality, especially in young women and underserved populations, partly because molecular heterogeneity makes diagnosis and treatment selection difficult and often a case of trial and error. The Oklahoma Rheumatic Disease Resources Cores Center helps address these complex disorders by providing centralized access to large collections of well-characterized, diverse patient samples, clinical research infrastructure for new recruitment, investigator and clinical trialist mentoring, expert consulting, and cutting-edge resources. Our Center has long-standing success launching the independent careers of 33 Junior Center Investigators and fostering a host of collaborations, and we commit to expanding these skills and resources to improve the understanding of rheumatic disease mechanisms and patient outcomes.